Identifying Multi-Scale Mechanisms for Age-Related Increase in Metabolic Cost of Walking

Mobility serves as a surrogate for well-being with age-related limits to walking function that include: increased
energy cost and decreased speed. In 2021, the National Institute on Aging convened interdisciplinary scientists
to identify multi-scale mechanisms for mobility impairments in aging and identified multiple factors contributing
to elevated metabolic cost and reduced walking speed. A foundational age-related difference in walking function
emerged - the so called ‘distal to proximal shift’ in neuromechanical effort. Older walkers rely more on proximal
hip rather than distal ankle muscle-tendons to power gait. This proposal leverages a multi-scale,
computational-experimental approach to probe cellular-to-behavioral mechanisms linking the ‘distal-to
proximal’ shift to increased energy cost and decreased walking speed with age. The central hypothesis is
that older adults select slower gait speeds to prioritize stability over economy, and these ‘safer’, proximally-
biased gaits combine with declines in neuromuscular efficiency creating a ‘lose-lose’ combination that elevates
the metabolic cost of walking. Aim 1: Characterize age-related differences in the relationship between lower-limb
joint mechanics and metabolic cost of ‘ecologically-relevant’ walking. Approach: GaTech will recruit n=60 [n=30
(15M/15F) young adults (YA) 18 – 30y and n=30 (15M/15F) older adults (OA-sed) ≥60y]. Outcomes: Net
metabolic power, lower-limb muscle activity and joint kinematics/kinetics during ‘ecologically-relevant’ outdoor
walking with a novel sensor suit using custom-trained machine-learning algorithms. Ankle and hip exoskeletons
to probe joint-level mechanical efficiency. Expected results: OA-sed>YA net metabolic power associated with
higher, more proximal and less efficient lower-limb joint power. Aim 2: Examine how age-related changes in
proximal-to-distal musculotendon structure and cellular/molecular muscle function impact metabolic cost of
walking. Approach: IHMC will recruit YA+OA-sed (same as Aim 2) plus n=30 (15M/15F) ≥60y physically activity
OA (OA-fit). Outcomes: Treadmill outcomes from Aim 2, distal-to-proximal musculotendon profiling, lateral
gastrocnemius (distal) and vastus lateralis (proximal) muscle biopsies for mitochondrial function, myofiber
type/size/grouping, targeted mitochondrial/metabolic molecular analyses. Expected results: OA-sed < OA-fit <YA
net metabolic power associated with proximally-biased reductions in muscle force capacity/mitochondrial
function. Aim 3: Determine the influence of task-level priorities on observed age-related increases in metabolic
cost of walking. Approach: Predictive musculoskeletal simulations that satisfy a pre-defined walking energy-
stability criterion. Outcomes: Predicted lower-limb muscle activations, joint and musculotendon kinematics and
kinetics, and metabolic energy cost of walking for simulations with old vs. young. Expected results. Data-driven
simulations will match experimental muscle activations from Aims1+2. Impact: Computational-experimental
approach identifies key age-related differences in muscle biology, musculotendon structure-function,
joint-level mechanics and task-level prioritization that drive elevated metabolic cost of walking in aging.

Public health relevance
Mobility serves as a surrogate for well-being and walking functional ability is associated with reduced mortality and greater quality of life. Aging negatively impacts walking performance causing increased metabolic cost of transport and decreased walking speed. Guided by recommendations from a National Institute on Aging expert panel, this proposal leverages a multi-scale, computational-experimental approach to probe molecular/cellular, tissue/joint biomechanical and behavioral mechanisms linking the age-related ‘distal-to proximal’ shift in motor coordination to elevated cost and reduced speed of walking in old age.